ARISEN (Autoimmunity, Rasmussen’s, Inflammation & Status Epilepticus research Network)

Career Enhancement Core – Project Summary
The overall goal of the Autoimmunity, Rasmussens, Inflammation & Status Epilepticus Research Network
(ARISEN) Career Enhancement Core (CEC) is to encourage, support, and train the next generation of
clinical/translational investigators studying rare neuroinflammatory disorders including autoimmune
encephalitis, Rasmussens, and NORSE. There is a shortage of physician-scientists studying rare
neuroinflammatory diseases, particularly those with pediatric expertise. The ARISEN CEC will cultivate an
efficient and effective pathway for current and future investigators dedicated to this area of research with the
ultimate objective of developing a collaborative, diverse, and multi-disciplinary community dedicated to
researching these diseases. To achieve these goals, the CEC will build on strong existing infrastructure,
institutional resources, and the team’s expertise to encourage, support, and train promising investigators new
to researching these diseases. We will use comprehensive evaluation tools to track publications,
presentations, funding, new collaborations, and perform qualitative assessments. The CEC leadership is a
multidisciplinary and expert leadership team and a resource-rich foundation that will be complemented by the
meaningful involvement of successful rare disease research faculty who all have strong track records of
successful research mentoring. The ARISEN CEC will achieve these goals through the following aims:
Aim 1 will provide outreach, networking, and broad curricular educational opportunities to attract, mentor,
support, and retain trainees and new researchers in fields related to rare neuroinflammatory disease research.
We will recruit an ARISEN investigator cohort comprised of early-stage investigators and researchers new to
the field pursuing neuroinflammatory disease research. We will host monthly seminars and partner with patient
advocacy groups to organize panel discussions with patients and caregivers highlighting their experiences and
challenges. Inviting medical students, residents, and fellows to attend the patient days will be done with the
purpose of inspiring researchers early on in their training. Aim 2 will focus on supporting future endeavors in
rare disease research through mini-grant funding opportunities named the “ARISEN Opportunity Fund” to early
stage and new investigators removing barriers to critical career-enhancing activities. These funds will be used
for conference travel, publication costs, specialized career development training, and collection of preliminary
data to facilitate the pursuit of rare disease research. The CEC is expected to award several smaller awards to
encourage and facilitate the research of multiple investigators each year. Aim 3 will provide customized
mentored training to accomplish rare disease research through: 1) a concierge approach with customized
course and workshop recommendations, 2) specialized seminars and panel discussions on the fundamentals
of developing multi-center patient registry infrastructure and 3) creating an exchange program to facilitate
invited talks and specialized hands-on training opportunities for these investigators from other institutions.